Role of PTPN2 in rheumatoid arthritis

ABSTRACT
The objective of this grant application is to understand how loss-of-function genetic variants of the PTPN2 gene
-encoding the T cell-protein tyrosine phosphatase (TC-PTP)- enhance risk of rheumatoid arthritis (RA). PTPN2
is ubiquitous, and very highly expressed in immune cells and is a critical negative regulator of Janus kinases and
signal transducers and activators of transcription downstream multiple cytokine receptors. In order to model the
mechanism of action of PTPN2 autoimmunity-associated variants in RA, we assessed mice carrying Ptpn2
haploinsufficiency (Ptpn2+/- mice), which causes a loss of expression of PTPN2 comparable to the human PTPN2
RA-risk variants. We found that in the SKG RA model- characterized by CD4 T cell-driven disease- partial loss
of function of PTPN2 caused significant enhancement of arthritis severity. By leveraging conditional Ptpn2
haploinsufficiency and fate-mapping mice, we showed that the phenotype of SKG.Ptpn2+/- mice is due to
enhanced inflammation-induced FoxP3+ regulatory T cell (Treg) instability, a process known to lead to conversion
of peripheral FoxP3+ Treg into pathogenic FoxP3- “exTreg” expressing interleukin-17 (IL-17). We have evidence
that the enhanced conversion of Ptpn2+/- Tregs into IL-17-producing “exTreg” is due to increased STAT3
phosphorylation after stimulation with IL-6 and potentially other inflammation-induced factors. Here we apply for
funding to further understand the mechanism of action of PTPN2 in Treg instability and the pathogenesis of RA
via mouse immunology and cell signaling studies. In Aim 1 and 2 we will elucidate the mechanism and topology
of enhanced inflammation-induced instability and pathogenicity of SKG.Ptpn2+/- Treg. In Aim 3 we will assess
whether overexpression of PTPN2 in Treg can reverse the Treg and arthritis phenotype induced by Ptpn2+/- in
SKG mice. Our long-term goal is to acquire knowledge of PTPN2 functional genetics to enable the discovery of
personalized and non-immunosuppressive therapies for RA patients carrying genetic PTPN2 risk variants.

Public health relevance
NARRATIVE We have modeled in genetically manipulated mice a loss of function variant of a gene called PTPN2 that enhances risk of rheumatoid arthritis, and found that it enhances arthritis severity. Initial studies of our genetically manipulated mice point to an abnormality in an immune cell population that normally protect humans from autoimmune arthritis. In this grant we will leverage available and new mouse models to understand the mechanism of action of PTPN2 in arthritis which could pave the way to personalized therapy of arthritis for PTPN2 risk variant carriers.